Adapting and testing an adjunctive, digital single-session intervention to increase caregiver adoption of early childhood mental health preventive services

PROJECT SUMMARY — RESEARCH PROJECT 2 (RP2)
The American Academy of Pediatrics has endorsed primary care-based screening of mental health risk in young
children as a key step toward improving youth mental health, but most early childhood mental health risks go
undetected and unaddressed. Even when they receive screening, only 10%-25% of young children identified as
“high risk” access mental health care. The availability of transdiagnostic decision tools for risk identification is a
major advance; however, increasing uptake of post-screening mental health resources will require a community-
partnered approach that centers families' needs, concerns, and experiences with mental health systems. Such
approaches must address caregiver preferences for certain types of support (e.g., for briefer, primary care-based
resources); address caregivers' beliefs and concerns that constrain help-seeking (e.g., beliefs that mental health
interventions will not help their child); and grant agency to caregivers navigating complex support systems. Given
the outsized impact of early prevention, there is a need for accessible adjunctive interventions that empower
caregivers to increase their likelihood of seeking recommended supports after a positive screening for mental
health risk at toddler pediatric well visits. Online single-session interventions (SSIs) have shown promise in
increasing caregiver receptivity to mental health intervention and increasing linkage to intervention. For example,
a digital (online) “growth mindset” SSI (GM-SSI, developed by Project Lead Schleider) teaching that emotions
are malleable has strengthened both child mental health and caregiver support-seeking across multiple trials.
Research Project 2 (RP2) of the Mental Health, Earlier (MHE) Center seeks to adapt an online, evidence-based
GM-SSI for caregivers of young children (ages 24-30 months) and test its potential to bridge the gap between
primary care-based mental health risk screening and families' access to child mental health support. When
integrated into the Center's Roll-Out Implementation Optimization design, it will bridge the Signature Project's
early identification decision tool and referral to the Family Checkup Online intervention. First, we will use human-
centered design methods to ensure the GM-SSI is developmentally and culturally informed for early childhood
primary care, via co-design with end-users (racially/ethnically minoritized caregivers) and key informants
(pediatricians, administrative staff). Second, via usability testing, we will collect pre-, post-, and follow-up data
on mechanisms (beliefs about mental health support; agency; hopelessness) and 3-month clinical outcomes
(child mental health support access) of the GM-SSI. Third, we will use these results and conduct a pilot trial
involving 30 primary care clinics and 350 caregivers of children screened as showing moderate-or-greater mental
health risk. We expect caregivers who receive the adapted SSI (vs. the control) to report larger improvements in
agency, hopelessness, and optimism about mental health support, and higher rates of accessing child mental
health support within 6 months of risk screening. Outcomes will be examined for equity across demographic
groups (e.g., racial/ethnic groups).